High subzero heart preservation: from zebrafish to mammals

PROJECT SUMMARY
Heart transplantation is the only cure for end-stage heart disease; however, an increasing imbalance between
demand and supply has limited access to this life-saving procedure. Extending the length of time hearts can
remain alive during transport represents a critical enabling technology to address several limitations in heart
transplantation. For example, usable hearts are discarded due to circumstantial factors, such as the timing of
donor death and donor/recipient location, which can be eliminated by extended preservation. Further, longer
preservation duration has the potential to improve recipient outcomes by enhancing donor-recipient matching,
reducing ischemic injury, and removing the risk of emergency surgeries. Consequently, this project aims to
develop a new method to extend preservation of hearts for transplantation from 4-6 hours to 3+ days.
While we have mastered the preservation of several clinically relevant cell types in suspension, solid organs
have been met with limited success since different cell types have different responses to the same injury.
Further, high throughput experimental methods to aid development of preservation solutions are limited since
intact tissue has 3D structural considerations that have a profound effect on successful preservation and
commonly used in vitro cell models are not representative and lack assessment of functional outcomes.
Instead, we propose to strategically leverage zebrafish transgenic lines to address cell-specific responses,
functional consequences, and compounding injuries of preservation approaches with an intact, native heart in
a high throughout format. Approaches developed in zebrafish will be rapidly scaled to mammalian hearts to
promote translation.
We will leverage this experimental platform to enable the development of a new preservation approach, termed
partial freezing. Inspired by freeze-tolerant wood frogs in nature, partial freezing aims to maximize storage
durations by entering unexplored high subzero temperatures ranges approaching -20°C. To enter these
temperature ranges, we will develop effective strategies for hearts to live in the presence of ice. This will be
achieved through the development of a storage solution designed to protect diverse cardiac cell types without
adverse functional consequences (Specific Aim 1). These efforts will be complimented by the discovery of
inducers that activate hypoxia signaling (Specific Aim 2) and the unfolded protein response (Specific Aim 3) to
rescue hearts from ischemic and temperature-dependent injury, respectively. These inducers will be combined
into a preconditioning solution that is delivered during machine perfusion to further extend preservation time.

Public health relevance
PROJECT NARRATIVE Extending heart preservation will overcome critical bottlenecks in transplantation by increasing the availability of hearts, improving long-term patient outcomes, reducing the cost of transplantation, and provide an untapped resource of hearts for research. This project aims to systematically address cell-specific responses and functional consequences of extended preservation and develop targeted strategies to deal with multiple modes of injury, including ischemia and temperature-related stressors.